Sulfur Amino Acid Metabolism and Regulation of Hepatic Metabolic Flexibility

Project summary
It is increasingly recognized that non-alcoholic steatohepatitis (NASH) is a prevalent liver disease with
complex and heterogenous underlying causes. Now, new evidence suggests that dysregulated hepatic sulfur
amino acid metabolism is associated with advanced human NASH and causes markedly worsened steatosis
and injury in genetic mouse models. However, significant knowledge gaps exist in our understanding of how
sulfur amino acid metabolism modifies NASH severity, and what mechanisms control hepatic sulfur amino acid
metabolism in normal physiology and liver diseases. This proposal builds on our discovery that CoA
metabolism is a key missing link between impaired hepatic sulfur amino acid metabolism and liver fat
accumulation and injury in NASH. We aim to establish a novel pathogenic mechanism whereby hepatic
availability of cysteine (a CoA synthesis substrate) is critical in maintaining the mitochondrial CoA pool to
support fatty acid oxidation. However, dysregulated sulfur amino acid flux in advanced NAFLD reduces
cysteine availability that impairs CoA synthesis. Hepatic CoA insufficiency in turn limits the liver’s ability to
adapt to increased fatty acid influx, creating a condition termed metabolic inflexibility that promotes
mitochondrial dysfunction, steatosis and oxidative stress. Mechanistically, we have identified that impaired
methionine adenosyltransferase 1A (MAT1A), which drives upstream methionine cycle-transsulfuration flux to
produce cysteine, and overactivation of cysteine dioxygenase type-1 (CDO1), which mediates downstream
cysteine elimination, contribute to such pathogenic condition by causing imbalanced cysteine input and output
in NAFLD. Further study revealed intriguing crosstalk of bile acids, TFEB, and FGF15/19 signaling regulation
of MAT1A and CDO1 to control hepatic sulfur amino acid and CoA metabolism under normal physiology and
NASH. We have developed novel mouse models that allow us to manipulate hepatic sulfur amino acid flux at
the two key regulatory steps (MAT1A, CDO1). In Aim 1, we will use hepatocyte-specific inducible CDO1
transgenic mice and hepatocyte-specific CDO1 knockout mice to study how altered CDO1 expression
downstream of bile acid signaling impacts hepatic sulfur amino acid, CoA and GSH metabolism to modulate
NASH severity. In Aim 2, we will use liver specific MAT1A gain-of-function and loss-of-function mouse models
to establish the significance of the MAT1A in regulating hepatic sulfur amino acid, CoA and GSH metabolism,
and further investigate how FGF15/19 and TFEB regulate MAT1A-driven sulfur flux and CoA metabolism in
physiology and NASH. By defining a new pathogenic link of sulfur amino acid metabolism to CoA metabolism
and delineating novel mechanisms regulating hepatic sulfur amino acid and CoA metabolism, we expect that
this study may advance the field by providing not only new insights into the mechanisms driving NASH
progression but also molecular basis for developing future therapeutic interventions.

Public health relevance
Project Narrative Identification of novel pathogenic factors that modulate fatty liver disease severity is of both basic science and clinical significance. This study aims to understand how altered sulfur amino acid metabolism contributes to liver fat accumulation and inflammation in fatty liver disease. In addition, this study investigates the mechanisms regulating hepatic sulfur amino acid metabolism and if they serve as potential therapeutic targets for treating fatty liver disease.